Microfracture-based Repair for Temporomandibular Joint Osteoarthritis

SUMMARY
Temporomandibular joint (TMJ) osteoarthritis (OA) is characterized by degeneration of the condylar cartilage.
No effective therapies exist for restoring the damaged cartilage to accommodate pediatric patients'
craniomaxillofacial growth. Regenerative therapies are needed to repair TMJ cartilage. Microfracture is a
technique where perforations are created through the subchondral bone to allow for bone marrow mesenchymal
stem cell (MSC) infiltration to create fibrocartilaginous repair tissue. However, MSCs are difficult to localize to
the damaged area without a scaffold, and their phenotype is prone to calcification. Matrix-autologous
chondrocyte implantation (MACI) is the most effective knee repair approach, where autologous knee
chondrocytes are seeded on a collagen scaffold and then implanted in the defect. However, MACI is costly,
requires two invasive procedures, and may not be applicable to the narrow TMJ for chondrocyte extraction.
Additionally, the collagenous scaffolds that are used for knee repairs do not recapitulate the native TMJ
extracellular matrix environment. The objectives of this F32 training grant are to develop regenerative
approaches to heal damaged TMJ cartilage for pediatric patients and train me in these approaches to
complement my tissue engineering background. Using fibro-elastic cartilage of porcine meniscus, we will use
our Meniscal Decellularized (MEND) scaffold to help localize and inform progenitor cells, such as ear cartilage
progenitor cells (eCPCs) or MSCs. We hypothesize that regenerative therapy adapting microfracture and
MACI/matrix-induced chondrogenesis can be used to repair the damaged TMJ condylar cartilage. We will first
compare the in vitro chondrogenic potential and phenotypic stability of eCPCs and MSCs in MEND. Outcomes
will include biochemical assays, mechanical testing, immunohistochemistry, histology, and gene expression.
Then, to assess in vivo phenotypic stability of the constructs, we will subcutaneously implant cell-seeded MEND
in immunocompromised mice and analyze outcomes via biochemical assays, immunohistochemistry, histology,
and gene expression. Next, we will compare the repair of adapted microfracture (simulated by an MSC injection)
and MACI (simulated by empty or eCPC MEND) for porcine and human TMJ condylar cartilage regeneration in
vivo using the semi-orthotopic mouse model and analyze outcomes via biochemical assays,
immunohistochemistry, histology, and gene expression. These studies will uncover whether microfracture
regenerates TMJ condylar cartilage and if a scaffold, potentially cellular, is needed to improve condylar
regeneration. Results will inform development of regenerative therapies for degenerated TMJ condylar cartilage
and produce preliminary data for a K99 application to support my training as an independent researcher in the
TMJ oral and craniofacial research field.

Public health relevance
NARRATIVE Regenerative therapies are desperately needed to effectively repair temporomandibular cartilage as current therapies are unable to accommodate craniofacial growth, especially for pediatric patients. Using porcine and human explants as well as in vivo techniques, this proposal tests the application of a modified microfracture and matrix-induced chondrogenesis approach to regenerate the temporomandibular cartilage leveraging our expertise in decellularized matrix scaffolds and cartilage progenitor cells.